Dissecting the influence of DNA damage response and homologous recombination deficiencies on tumor immunogenicity

PROJECT SUMMARY
This Diversity Supplement will support the career development of Ezekiel Olumuyide who will
perform PhD thesis studies under the mentorship of Robert Samstein. The parent grant (DP5
grant OD028171, “Dissecting the influence of DNA damage response and homologous
recombination deficiencies on tumor immunogenicity”) will examine the immunogenicity of
DNA repair defects on the innate and adaptive immune responses. In this supplement proposal,
Ms. Olumuyide will utilize a novel protein-barcoded CRISPR screen technology to assess a wide
panel of genes. The candidate career development plan will include intensive training in oral and
written communication, grant writing, technical skill development with experimental mouse
modeling and immunophenotyping, and didactic training in computational immunology.

Public health relevance
This Diversity Supplement will support the career development of Ezekiel Olumuyide for his early work towards his thesis studies on immunogenicity of DNA repair defects. This will complement the studies proposed in the parent grant “Dissecting the influence of DNA damage response and homologous recombination deficiencies on tumor immunogenicity”. This supplement will promote diversity at a national level by support of the candidate's long term career goals that include study and incorporation of diverse populations in biomedical research.